Harnessing B Cells after Stem Cell Transplant to Produce Novel CAR-Ts

Abstract:
Hematological malignancies like leukemias, lymphomas and multiple myeloma are all too often incurable
without highly toxic immunotherapy like allogeneic hematopoietic stem cell transplantation (HCT). The advent of
less toxic and more targeted, engineered chimeric antigen receptor (CAR) cytotoxic cells has been a major
advance. Unfortunately, use of CAR-engineered cells is available only to a small subset of cancer patients whose
tumor cells express known antigens. This limitation is due to the inability to produce the tumor-targeting, antigen-
binding part of the chimeric receptor. This critical cell surface antigen-targeting part of a CAR, the single chain
fragment variable region (or scFv) is not derived from a T cell. The scFv is derived from antibody-producing, B
Cell Receptor (BCR)-Activated B cells because antibodies, unlike T Cell Receptors, bind to three-dimensional
structures on tumor cell surfaces in an unrestricted manner. Our objective is to leverage what we have learned
about the mechanisms of B cell tolerance in patients who develop immune toxicity and have decreased cancer
relapsed rates to ask whether anti-tumor B cells can be cloned from patients after HCT to engineer less toxic,
more targeted immune cell that eradicate hematological malignancies.
Important findings regarding B cells by our group and others over the last 15 years have revealed that
host and tumor-reactive B cells survive after HCT when immune tolerance mechanisms are broken in patient
with chronic graft versus host disease (cGVHD). Altered immune homeostasis/balance after HCT, donor B cells
develop under constant activation of the B Cell Receptor (BCR) by ubiquitous alloantigens (foreign/host and
tumor antigens) and excess B Cell Activating Factor (BAFF). Both alloantigen activation of the BCR and BAFF
promote survival of B cells that potentially produce polyreactive antibodies. Thus, we hypothesize early after
HCT, B cells are primed for production of antibodies with tumor-binding potential. In Aim 1, we will employ HCT-
related factors that promote BCR-activated B cells in order to clone cells that would otherwise die via immune
tolerance death mechanisms. In Aim 2, we will establish a tumor identification strategy using pooled CRISPR
knockdown in a flow cytometry-based assay. Our immediate objective in this R21 proposal is to understand and
overcome barriers by harnessing human tumor antigen-responsive, antibody-producing B cells and methods that
identify tumor binding receptors (scFV) to engineering novel cancer-eradicating CARs. We will capitalize on what
we’ve learned about B cell tolerance after HCT, along with our collaborators at Duke, to establish a pipeline for
B cell for rapid cloning of key anti-tumor antibody fragments, scFv, for CAR production.

Public health relevance
Project Summary/Narrative: Instead of their own receptors, T cells can be engineered to express chimeric antigen receptors (CARs) comprised of B cell receptors that recognize 3-D tumor antigens on cells without being restricted by Human Leukocyte Antigen (HLA). Still, CAR-T cells are not available to all patients because only a small set tumor types are targeted by known B cell receptors (BCR). In this proposal, we capitalize on what we previously published about BCR-activated B cells that arise after donor stem cell transplant when residual blood-borne tumor is present, so we will clone novel tumor-binding receptors from patients and produce CAR T cells that can be used to treat all patients with blood-borne cancers.